IncRNA BORG Mediates Alternative Splicing to Enhance Cellular Plasticity in TNBC

Project Summary/Abstract
Breast cancer (BC) is the second leading cause of cancer-related deaths among women in the United States. A
subset of BC called triple-negative breast cancer (TNBC) has the worst prognosis among BC subtypes, due to
both the frequency and location of the resulting metastases. In TNBC, the underlying mechanisms that mediate
metastatic outgrowth after disseminated tumor cells implant into distal sites is unknown. However, our laboratory
recently identified the long noncoding RNA, BORG (BMP/OP-Response Gene), as a driver of TNBC metastasis.
Indeed, BORG expression enhances neoplastic proliferation and chemoresistance, which are important cellular
functions associated with metastatic phenotypes. Mechanistically, our group showed that BORG complexes
with the E3 SUMO ligase TRIM28 in order to enhance neoplastic proliferation by repressing the expression of
the growth arrest genes, p21 and gadd45a. Herein, I will show that the proliferative and cell survival pathways
activated by BORG reflect breast cancer stem cell (BCSC) phenotypes. Importantly, I demonstrate that BORG
enhances BCSC mammosphere formation and tumor growth both in vitro and in vivo, and that this phenotype
relies in part on the formation of BORG:TRIM28 complexes. However, the mechanisms through which BORG
and TRIM28 enhance BCSC plasticity are not yet understood. To this end, I find that BORG expression causes
significant transcriptomic reprogramming, suggesting that BORG enhances cellular plasticity by mediating transcriptomic changes (e.g., alternative splicing) which broadly influences BCSC-like phenotypes. Accordingly, I
showed that BORG expression plays a role in alternative splicing by upregulating 61 alternative splicing events
(ASEs) and downregulating 83 ASEs, including a number of ASEs whose genes are involved in key metastatic
pathways. Moreover, I determined that BORG downregulates the expression of 38 splicing factors, and up-
regulates the expression of 6 splicing factors. Interestingly, the downregulation of 16 of these splicing factors
relies upon BORG:TRIM28 complexes. Based on these preliminary data, I hypothesize that BORG:TRIM28
complexes drive BCSC plasticity and metastasis by regulating the epigenome and ASEs involved in metastatic
phenotypes. To elucidate how BORG influences alternative splicing, I will (i) determine the mechanism(s) by
which BORG:TRIM28 complexes regulate the expression and activity of splicing factors to drive variations in alternative splicing; and (ii) elucidate the consequences of BORG-induced ASEs on tumor cell plasticity and BCSC
phenotypes. To our knowledge, my innovative analyses are the first to investigate the interaction between BORG
and alternative splicing in promoting the metastatic features of TNBCs. By elucidating molecular mechanisms
whereby BORG drives alternative splicing, we can better understand how lncRNAs elicit such drastic phenotypic
changes to drive metastatic behaviors in TNBCs. Importantly, BORG-induced ASEs may provide new therapeu-
tic targets to treat and alleviate metastatic TNBCs.

Public health relevance
Project Narrative Breast cancer has a high incidence rate and remains a major health concern in the United States, and the majority of breast cancer-related deaths are due to metastasis, which lacks effective targeted therapeutics. Recently, the long noncoding RNA BORG was shown to play an important role in driving the metastasis of breast cancers, as well as breast cancer proliferation and chemoresistance, but the mechanism through which BORG promotes these metastatic phenotypes remains unclear. I find that BORG is essential for breast cancer “stemness,” and as such, I will establish how BORG contributes to breast cancer stemness and metastasis, thereby identifying novel therapeutic targets with the potential to alleviate metastatic disease.